Mechanisms of HDL-Mediated LPS Neutralization and Transport in the Portal Vein

Project Summary/Abstract
Apolipoprotein A1 (ApoA1) is the core protein constituent of high density lipoprotein (HDL). Previous work from
our lab has shown that enteric HDL plays a critical role in the neutralization of lipopolysaccharide (LPS) that
leaks from the gut. LPS rapidly binds circulating HDL and is neutralized, preventing chronic activation of TLR4
which leads to inflammation and liver fibrosis. However, the mechanism by which HDL neutralizes LPS is not
completely understood. The liver derived LPS binding protein (LBP) is known to associate with HDL and play a
critical role in the neutralization of HDL bound LPS. To address the mechanism by which LBP bound HDL
from the intestine neutralizes LPS, I will determine the protein constituents of the LPS neutralizing
complex and measure the capacity of different reconstituted lipoprotein complexes to neutralize LPS.
To investigate the mechanism of how HDL neutralizes LPS, I will use proteomics and lipidomics to characterize
LBP+ HDL particles. I will also use a novel flow sorting method to detect proteins on intact HDL complexes
derived from plasma sources. Using recombinant protein and lipids, I will reconstitute this complex and
measure the neutralization of LPS using HEK-BLueTM-4 cell assay. Another outstanding question is how HDL
is trafficked from the small intestine into the portal venous circulation prior to reaching the liver. Our previous
research suggests that lipidation of ApoA1 by intestinal ABCA1 is necessary for efficient transport of HDL to the
portal venous circulation. Knockout of ABCA1 in the intestine led to a dramatic reduction in the circulating
levels of HDL in the portal vein and led to greater liver inflammation and fibrosis. One possibility to explain
these results is that lipidated HDL binds to scavenger receptor class B type 1 (SRB1) which is known
to play a role in the transcytosis of HDL across the endothelial membrane. An alternative hypothesis is
that the fenestration of the microvasculature in the villi of the small intestine allows for the passive
filtration of HDL into the venous circulation. To distinguish between these two hypotheses, I will use a
photoconvertible fluorescent protein, KikumeGR, tagged to ApoA1 to measure trafficking of HDL from
the small intestine to the portal vein. To investigate the role of SRB1 on trafficking of enteric HDL to the
portal vein, I will cross SRB1fl/fl mice to Cdh5α-CreERT2 mice, which will remove SRB1 from vascular
endothelial cells. To test whether HDL from the small intestine egresses through fenestrae in the
microvasculature, I will use PE-conjugated anti-PLVAP antibody (PLVAP forms a diaphragm regulating solute
passage through fenestrae) which will block passage of solutes through fenestrae. To measure HDL trafficking
from the small intestine to the portal vein, I will transduce mice using AAV expressing KikGR-ApoA1, which can
be photoconverted from green to red fluorescence in the small intestine using 405nm light, which can then be
detected in the portal vein. Together these experiments will help to mechanistically define the trafficking of HDL
to the portal vein and the neutralization of LPS to restrain liver inflammation and injury.

Public health relevance
Project Narrative HDL from the small intestine plays a critical role in the neutralization of LPS that travels from the small intestine to the liver via the portal vein to prevent chronic inflammation and liver fibrosis. The mechanisms underlying trafficking of enteric HDL to the portal vein and the mechanism by which HDL neutralizes LPS are currently not understood. The proposed experiments in this grant will delineate the mechanisms by which HDL enters the portal vein and the protein constituents of the HDL particles that neutralize LPS.